ONLINE COMMENTARY USE AND ANTIMICROBIAL PRESCRIBING

Several studies indicate that patient/parental pressure to prescribe antimicrobials, whether explicit or perceived, leads to increased rates of inappropriate prescribing. In preliminary work, the investigators have identified a communication technique used by pediatricians who often successfully resist inappropriate prescribing. This technique, called online commentary, is talk that describes what the physician is seeing, feeling, or hearing during the physical examination of the patient. The objective of the proposed study is to gain a better understanding of how physician use online commentary in response to both explicit and perceived parental expectations for antimicrobials in the pediatric outpatient setting. The investigators will accomplish this objective by analysis 306 pediatric acute care encounters for the presence of online commentary events. These data will be used in combination with already existing survey data to 1) explore the determinants of online commentary use by physicians; 2) examine the relationships between online commentary use and the physician's prescribing decision, the diagnosis assigned by the physician, and parent visit-specific satisfaction; and 3) to explore the relationship between unmet parental expectations for antimicrobials, physician use of online commentary and visit-specific satisfaction. This project takes advantage of substantial data already collected and therefore can accomplish more than the resources requested would suggest. The 306 transcribed audiotapes and survey data were collected as part of a study that took place in West Los Angeles from 10/96 to 2/97. The proposed study will proceed in three stages. First, the coding scheme used in preliminary work will be refined for the current study using a sample of 25 encounters. Second, the remaining 276 encounters will be analyzed for online commentary events using this revised coding scheme. Third, the audiotape transcript data will be merged with existing survey data for further analysis. The knowledge gained from this study will ultimately aid in the development of an intervention to change pediatrician antimicrobial prescribing practices. It will allow the investigators to determine whether online commentary is a useful communication technique that physicians could be trained to use in order to resist pressure for inappropriate antimicrobial prescribing.